DP19-001, Health Promotion and Disease Prevention Research Centers

Providing patient- and family-centered care to address physical and mental health needs of the growing
number of older adults in the United States is a national public health priority. Given the enormous personal
and societal costs associated with Alzheimer’s disease and related dementias, there is an urgent need to
implement and test patient- and family-centered approaches that would help detect cognitive changes at an
early stage and provide resources and support for older adults to age in place in safe environments where
they are understood, valued and respected. The purpose of this project is to pilot and test the feasibility
and effectiveness of the KAER (Kickstart, Assess, Evaluate, Refer) Model to improve cognitive
impairment detection and referral to resources for older adults in urban and rural primary care
outpatient settings in Illinois that serve diverse older adult populations. We will leverage findings to
guide refinement and expanded integration of the KAER Model into the health system. This project will
examine the public health impact of implementation of the KAER Model by primary care providers (PCPs) in
two settings (urban and rural) for timely and appropriate cognitive impairment detection and referral to
resources for older adults. We will review and refine the KAER Model and study the impacts of the enhanced
and expanded implementation. The project will have a very significant population health impact; it will improve
the timely detection of cognitive impairment and connect those identified with cognitive impairment to
appropriate resources and support to enhance the health and well-being of older adults. Patients and their
family caregivers will be able to better manage their overall health and plan for the future. Longer term, the
impact of integrating a refined KAER model has strong likelihood for improving the standard of care for persons
with cognitive impairment, benefiting patients, families and caregivers, as well as the health care system. The
urban primary care clinics in the proposed project are Family Medicine outpatient clinics that are part of the
University of Illinois Health (UI Health) System. The rural primary care clinics are outpatient clinics in the Illinois
Critical Access Hospital Network (ICAHN). The project is led by a strong leadership team with a proven track
record of success in health services research, health professions education and primary care geriatrics, as well
as a robust team of local and national experts who will serve on the project Advisory Board.
Specific Aim 1: Conduct a mixed-methods baseline assessment of urban and rural PCPs’ cognitive screening
practices using a survey and phone interviews.
Specific Aim 2: Pilot the KAER model with a small sample of primary care outpatient urban and rural PCPs.
Specific Aim 3: Use findings from the pilot and the baseline survey to review and refine the KAER model; train
a large cohort of urban and rural PCPs to implement the refined model (KAER-2); and evaluate the feasibility,
acceptability and effectiveness of the new patient-centered, culturally-competent KAER-2 intervention.
1

Public health relevance
Project Narrative The growing number of older adults in the U.S population has placed unprecedented demands on aging services and health care systems in both urban and rural settings; Alzheimer’s disease is a leading cause of death and the estimated total cost for health care, long-term care, and hospice for persons with Alzheimer's disease and related dementias was estimated to be $236 billion for 2016. The number of geriatrics-trained clinicians has not kept pace with the growing number of older adults and this gap is expect to widen, making it imperative that primary care geriatrics should be enhanced by integrating and testing novel approaches. By utilizing the KAER model to improve cognitive impairment detection and referral to resources among the older adult population in urban and rural settings, the findings of this research study will advance public health science and contribute to developing evidence-based best practices to optimize the health and well-being of older adults, improve patients’ experiences of care, improve population health, improve care-team well-being and reduce unnecessary health care cost, thus helping achieve the Quadruple Aim.